Spatiotemporal models of neural coding in the vestibular periphery

Project Summary
The vestibular inner ear detects head motion through displacement of mechanosensitive stereocilia bundles on
hair cells (HCs). Primary vestibular afferents encode these bundle deflections using distinct firing patterns
referred to as regular and irregular based on the spike timing variability. Both afferent classes encode head
motions using spike rates but irregular afferents also encode features based on precise spike timing. HC and
afferents are modulated by efferent vestibular neurons located in the brainstem. Efferents lower HC voltage gain
but excite afferents and the larger impacts of efferent feedback on vestibular afferent encoding and vestibular-
mediated performance remain hypothetical.
Three key aspects of computation in the vestibular periphery remain to be investigated. First, vestibular afferents
have typically modeled single neurons to explain how a few biophysical properties influence neural coding.
However, these models do not capture the entire picture of how the vestibular periphery (i.e. the population of
HCs and afferents) encodes head motions. Second, the vestibular epithelium is spatially organized by preferred
stimulus direction and afferent subtype – irregular afferents emerge from the central region of the epithelium
(striola) while regular emerge from the peripheral zone (extrastriola). The zones show distinct physiological and
structural properties yet prior models have only incorporated a few. It remains unknown how these various
properties work together and contribute to neural coding. Finally, previous work has characterized how efferents
modulate spontaneous HC and afferent dynamics at a single unit level, yet how these modulatory effects
influence mechanically evoked responses (i.e. hair bundle deflections) as well as neural coding at a population
level is unknown.
The objective of this proposal is to develop circuit-level computational models of the vestibular periphery (i.e. a
population of HCs, afferents and efferent feedback) that incorporates voltage-gated ion channels, afferent
morphology, and topographical organization. These models will give us a higher-level perspective on how
biological properties, spatial organization and efferents influence both neural coding and response dynamics.
Our circuit-level models may also provide insight into vestibular efferents modulate and stabilize vestibular
functioning.

Public health relevance
PROJECT NARRATIVE The vestibular inner ear encodes head motions through the displacement of mechanosensitive hair bundles and distinct afferent firing patterns. Previous work has characterized hair cell and afferent properties at the single- cell level yet how head motions are encoded at the circuit-level is not well understood. The objective of the proposed study is to use hair cell and afferent voltage-gated ion channels as building blocks for circuit-level computational models that are more faithful to how the system encodes head motions.